Stress, Inflammation, and Neurocognitive Functioning in Adults with Huntington’s Disease

PROJECT SUMMARY
Huntington’s disease (HD) is a chronic, fatal neurodegenerative disease characterized by impairments in
multiple domains of neurocognitive functioning, particularly executive dysfunction (e.g., inhibitory control,
working memory). Notably, levels of impairment in executive functioning within HD are highly heterogenous
and the specific underlying mechanisms driving declines are not well understood. Evidence from seminal
reviews and longitudinal empirical studies (e.g., Slavich & Irwin, 2014; Zainal & Newman, 2022), have
identified chronic stress and inflammation as two important mechanisms that contribute to executive
functioning deficits in other populations. However, little to no research has investigated how stress and
inflammatory mechanisms may be contributing to declines in executive functioning in HD. The proposed study
will fill this gap in the literature by examining the contribution of chronic stress, inflammation, and disease
processes to impairments in executive functioning in a sample of adults with HD. The proposed study will
leverage access to participants in an ongoing NIH grant (R01HD104188; m-PI’s: Compas & Claassen) testing
the longitudinal associations among social connectedness and health behaviors in HD patients and their
families as compared to a community sample of families. The primary goals of the proposed study are three-
fold. First, this study will improve the quality of the measurement of stress in individuals with HD by adapting
and using state-of the art methodology (i.e., stress interviews with a blind rating component) to assess general
and disease specific stressful events in a sample of individuals with HD compared to a community sample of
adults. It is hypothesized that individuals with HD will exhibit a greater number of general acute and chronic
stressful events on average compared to a community sample of adults. Further, variability in disease specific
acute and chronic stress within the HD sample will be associated with relevant demographic and disease
characteristics (e.g., disease progression). Second, the proposed study will investigate two candidate
mechanisms, chronic stress and CAG by Age Product (CAP) scores (a standardized marker of disease
burden; Warner et al., 2022) that may contribute to heightened inflammatory processes in a HD sample. Lastly,
direct and indirect path analyses will examine associations of stress, inflammatory cytokines, and CAP scores
with impairments in executive functioning in a sample of individuals with HD. Because the proposed is
embedded within a larger, longitudinal grant, a portion of analyses for the final aim will be tested both cross-
sectionally and prospectively at 6-month follow-up. Training for the applicant will include development of new
skills with biological methods (i.e., inflammatory cytokine assays), data management and analyses, along with
an opportunity to expand knowledge on the biological underpinnings of stress and disease processes on an
important indicator of functioning, executive function. Finally, evidence from this proposal yields potential
important ramifications on treatment and intervention targets for supportive care in this population.

Public health relevance
PROJECT NARRATIVE Huntington’s disease (HD) is a chronic, fatal neurodegenerative disease associated with vast impairments in executive functioning; however, the presentation of executive dysfunction in HD is highly variable across disease progression and the underlying mechanisms driving these declines are poorly understood. Building on seminal findings of key contributors to executive dysfunction in other disease populations, the proposed study aims to extend these findings by examining the association of chronic stress, inflammatory cytokines, and a standardized marker of disease burden with executive functioning in a sample of adults with HD. This study will improve the field’s understanding of the specific processes driving one of the cardinal features of HD, executive dysfunction, and has the potential to inform treatment targets for supportive care.